American Society of Tropical Medicine and Hygiene: 2022 Annual Meeting

PROJECT SUMMARY ABSTRACT
The American Society of Tropical Medicine and Hygiene (ASTMH) is the largest international scientific
organization of experts dedicated to reducing the global burden of tropical infectious diseases and
improving global health. Through its annual scientific meeting ASTMH provides a unique platform to
build global tropical medicine/global health research capacity for national and international scientists
including those who work on pandemic threats through increased dissemination of the latest tropical
medicine research, by providing an open and safe scientific environment for cross-fertilization of ideas,
through building collaborations among labs, by incubating new ideas, and fostering career development
for students and trainees. During the meeting, leaders in the field offer practical insights and strategic
vision. More than 4,000 attendees from 110+ countries bring global perspectives. Four days of
concurrent sessions, posters, and an exhibit hall offer opportunities for collaboration and networking.
Attendees are tropical medicine research scientists from academia, government, foundations,
nonprofits and the private sector who work to reduce the burden of tropical diseases and improve
global public health.
The meeting is led by ASTMH members including an elected Scientific Program Chair, an appointed
Associate Chair, 135 expert appointed ASTMH members serving on subject matter committees that
review symposia and abstract submissions and award and honors applications, and ASTMH Subgroup
leadership to craft symposia in their area of interest and expertise. Priority is given to symposia proposal
that include original data and/or concepts that promote broad debate and synthesis presented by
experts in the field as well as to speaker panels that reflect ASTMH members in diversity and content
through gender, institutional background and country of origin.

Public health relevance
ASTMH 2022 Annual Meeting PROJECT NARRATIVE The ASTMH proposes to build capacity for global tropical medicine/global health research through its 2022 Annual Meeting. ASTMH’s annual scientific meeting is a platform that disseminates the latest tropical medicine research, provides an open and safe scientific environment for cross-fertilization of ideas, builds new collaborations among labs, incubates new ideas, and furthers career development and builds access for students and trainees. The 2022 Annual Meeting will be held October 30 – November 3, in Seattle, Washington, United States of America, at the Washington Convention Center. 1